Developing novel targeted therapeutics integrated with immunotherapy-based approaches to make breakthroughs in metastatic breast cancer

Project Summary/Abstract
Metastatic breast cancer (MBC) is a devastating disease that accounts for over 90% of breast cancer mortality
and for which there are no current effective treatments. With over 230,000 new breast cancer cases diagnosed
annually and accounting for more than 40,000 deaths every year in the United States alone, developing safe
and effective treatments for MBC is an utmost priority. Our research program proposes to address this
important disease by combining basic and pre-clinical studies that can translate into meaningful clinical
outcomes for patients with MBC. Prompted by an increasing understanding of the molecular mechanisms
underlying oncogenic dependence and resistance to therapy, the advent of targeted therapies, and, most
recently, of immunotherapy, has revolutionized our approach to modern cancer treatment. These advances,
together with improved models and novel technologies, open the door to tackling some of the hardest
challenges in cancer treatment. We will capitalize on our expertise on signal transduction and pharmacology,
as well as on our previous findings on targeted drug resistance and sensitivity, to design safe and effective
targeted therapies against MBC. Specifically, we will investigate the role of PTEN and specific PI3K isoforms in
metastatic spread using multiple genetically-engineered mouse models (GEMMs) and patient-derived
xenografts (PDXs). We will also evaluate the use of combined immunotherapy and targeted PI3K isoform-
specific inhibition on syngeneic mouse models of MBC. In addition, we will thoroughly research two recently
discovered and promising novel targets, Maternal Embryonic Leucine-zipper Kinase (MELK) and CDK7, which
proved to be essential in basal-like or triple negative breast cancer, but dispensable in normal cells, for their
role in normal cell physiology and cancer pathogenesis, and for potential targeting in MBC. Importantly, we will
invest considerable efforts into researching breast cancer brain metastasis (BCBM), a disease that has been
largely neglected due to a lack of clinically relevant models and the difficulty to explore new treatment
approaches. To this end, we will use novel orthotopic PDX models of BCBM that faithfully recapitulate genetic
and phenotypic characteristics of the original patient samples, to investigate targeted drug combination
therapies and resistance. There is a yet unmet need to develop safe targeted therapies against MBC, to
thoroughly investigate combined immunotherapy and targeted therapies in breast cancer, and to discover
effective treatments against BCBM. We have the experience, expertise and support to carry out these studies,
and we are confident that we can make a significant contribution to the field of metastatic breast cancer, and to
the many patients and families afflicted by this disease.

Public health relevance
Project Narrative Patients suffering from metastatic breast cancer (MBC) frequently face a dismal prognosis, with only limited and often ineffective treatment strategies available to them. In this project, we will aim to deliver on the promise of precision medicine by developing novel targeted therapies against specific molecular abnormalities found in MBC. If successful, the results from this study have the potential to dramatically affect the lives of many patients suffering from MBC by providing effective and safer therapeutic options.